Regulation of IgG Sialylation

Project Abstract:
The association between decreased plasma IgG sialylation and a variety of inflammatory diseases has
been known for decades. The downstream effects of changes in IgG sialylation have been studied in depth, and
it is now believed that decreases in sialylation increase the affinity of IgG for activating Fc receptors, thereby
driving immune activation throughout the body. Although the downstream effects of dysregulated IgG sialylation
have been well documented, the regulatory mechanisms controlling IgG sialylation remain unknown. If these
mechanisms are elucidated, they may serve as novel therapeutic targets to manipulate IgG function to either
enhance or suppress IgG-based inflammation, depending on the circumstances. Previous research has
suggested that, unlike many other glycoproteins, IgG is not sialylated efficiently during the secretory process,
pointing to a B cell-extrinsic mechanism in which IgG sialylation is dynamically regulated following its release
into the bloodstream. Therefore, the goals of the proposed studies are (1) to identify key regulatory mechanisms
underlying IgG sialylation and (2) to elucidate how inflammatory signals are translated into changes in the IgG
glycan. The success of this study will be characterized by revealing a novel and dynamic mechanism regulating
IgG function through regulated changes in glycan sialylation, while providing cutting-edge scientific and
professional training that blends both glycobiology and immunology to facilitate a career trajectory focused upon
leadership in IgG-based therapies and translational science.

Public health relevance
Project Narrative: Autoimmune and inflammatory diseases affect tens of millions of people in the United States39 and are characterized by a significant reduction in IgG sialylation, although the mechanisms underlying this dysregulation remain unclear. Conversely, treatment with exogenous and sialylated IgG in the form of IVIg therapy reverses autoimmune inflammation and helps to restore homeostasis. This proposal seeks to elucidate the regulatory mechanisms underlying changes in endogenous IgG sialylation, which we believe will ultimately provide a novel therapeutic target for sufferers of chronic and autoimmune inflammatory conditions.